Collaborative Pediatric Critical Care Research Network

Project Summary
In 2005, the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD)
established the Collaborative Pediatric Critical Care Research Network (CPCCRN) to support multi-institutional
randomized controlled trials (RCTs) and observational studies in critically ill children. This PL1 proposal from the
University of Utah is submitted on behalf of a newly conﬁgured CPCCRN network increased to 12 Clinical Sites
and 12 ancillary sites with > 61,000 annual ICU admissions. The expanded network has geographic, racial/ethnic
and socioeconomic diversity, and will be a platform to develop additional investigators, especially young clinician
scientists. The network will conduct a highly innovative large-scale multi-center study of personalized, targeted
immune modulation in children with sepsis-induced multiple organ dysfunction syndrome (MODS). The study
includes two concurrent, immunophenotype-driven placebo controlled RCTs that will address the central hypoth-
esis that individualized, pathophysiology-speciﬁc immunomodulation will improve outcomes from sepsis-induced
MODS in children. This study builds on R01-funded CPCCRN studies that have demonstrated the existence of
speciﬁc immune phenotypes among children with sepsis-induced MODS (R01GM108618 PI: Carcillo) and suc-
cessful reversal of immunosuppression by administration of the immunostimulant granulocyte macrophage-colony
stimulating factor (GM-CSF) (R01GM094203 PI: Hall). It also complements the ongoing NICHD R01-funded study
investigating the risk factors for immunoparalysis in pediatric MODS (R01HD095976 MPI: Hall, Zuppa).
This application has three speciﬁc aims: (1) Implement the CPCCRN organization; (2) Mount a comprehen-
sive strategy for development of young clinician scientists and submission of rigorous proposals to fund additional
research in critical care; (3) Conduct the Personalized Immunomodulation in Sepsis-induced MODS study. The
ﬁrst trial focuses on the use of the drug GM-CSF for the reversal of immunoparalysis. The second trial uses
adaptive randomization and focuses on the drugs anakinra and tocilizumab for the targeted treatment of hyper-
inﬂammation. The primary outcome of both trials will be duration and severity of organ dysfunction using the
cumulative PELOD-2 score, and secondary outcomes will assess health related quality of life and family function-
ing at 3 and 12 months.
The Personalized Immunomodulation in Sepsis-Induced MODS study represents a paradigm shift in the man-
agement of pediatric sepsis, ﬁnally moving beyond simple supportive care. We are uniquely positioned to suc-
cessfully execute this approach to personalized, real-time, pathophysiology-directed sepsis treatment, leveraging
the strengths of a diverse and highly accomplished group of investigators to deliver high-impact science to the
beneﬁt of our patients and our ﬁeld.

Public health relevance
Project Narrative The Collaborative Pediatric Critical Care Research Network (CPCCRN) includes 24 pediatric intensive care units and an established Data Coordinating Center with independent medical and biostatistical expertise. Build- ing on its strong track record of successful clinical trials and innovative work in immune phenotyping in pediatric sepsis, the CPCCRN will carry out a large-scale multicenter randomized controlled trial using personalized test- ing and targeted management of immune function in infants and children with sepsis-induced multiple organ dysfunction syndrome (MODS), one of the most frequent causes of mortality and morbidity in critical care.